Center for Innovations in Quality, Effectiveness, and Safety (IQuESt)

ABSTRACT
Pursuant to the COIN RFA version 4.5 (HX-17-014), the executive summary has been included in attachment
00_Executive_summ.

Public health relevance
The Houston Health Services Research & Development (HSR&D) Center for Innovations in Quality, Effectiveness and Safety (IQuESt) has been continuously funded by HSR&D since 1990, providing strong scientific leadership and institutional infrastructure dedicated to a model of embedded health system research. We have a nearly 20-year tradition of conducting research in partnership with the health care delivery system and responding to its needs, making us pioneers in the execution of the learning health care system model in VHA. The IQuESt mission, “Improving health and well-being through innovations in health care delivery”, conveys our commitment to transformative and innovative research that is aligned with VHA national priorities. IQuESt is ideally poised to contribute to making care more accessible, safer, and more patient-centered with innovative research, rapid implementation of evidence, novel methodologies, solid partnerships, stakeholder engagement, career development of scientists, and infrastructure to promote the learning health care system in VHA.